Biostatistics and Data Management Core

PROJECT SUMMARY/ABSTRACT
Effective antiretroviral therapy has increased the lifespan of people living with HIV (PLWH). Alcohol use,
common among PLWH, plays an important role in the risk for and management of HIV-associated
comorbidities. Unhealthy alcohol use can exacerbate two prevalent HIV-related co-occurring conditions,
chronic pain and physical inactivity, which in conjunction with alcohol use affect physical and mental function
and are associated with a variety of HIV-related comorbidities. We propose the Boston Alcohol Research
Collaboration on HIV/AIDS – Comorbidity Center (Boston ARCH CC) as an extension of the Boston
Alcohol Research Collaboration of HIV/AIDS (ARCH). In Boston ARCH CC two clinical trials will test
interventions aimed at unhealthy alcohol use, pain, and physical inactivity, that impact a variety of other HIV-
related comorbidities. The ARCH CC BDM Core will work closely with ARCH CC investigators, providing
experience, expertise, and resources toward the planning, conduct, and data analysis of the work of Boston
ARCH CC. ARCH CC will also continue to make the existing Boston ARCH Cohort available for secondary
analyses, with a focus on mentoring and developing young investigators, and the ARCH CC BDM Core will
provide support for developing proposals and conducting analyses of the cohort. The first aim of the ARCH
CC BDM Core is to provide comprehensive data management and statistical support for the two ARCH
CC clinical trials. Both of these trials focus on behavioral telehealth interventions. Research Project
Component-Pain tests the efficacy of an integrated telehealth intervention incorporating motivational and
cognitive-behavioral management for reducing unhealthy drinking and chronic pain in PLWH. Research Project
Component-Physical Activity tests the efficacy of a home-based lifestyle physical activity intervention with
mobile-health delivered components to decrease unhealthy drinking and increase physical activity in PLWH.
The second aim of ARCH CC BDM is to support secondary analyses of the existing Boston ARCH
cohort, and provide support and mentoring to trainees and investigators accessing the cohort. The
Boston ARCH cohort enrolled PLWH with current or past unhealthy alcohol use, collecting longitudinal data on
alcohol and other drug use and disorders, HIV-related treatment and medication use, health-related behaviors,
and physical and mental function outcomes.